PHASE III TRIAL OF TOBRAMYCIN IN TREATMENT OF P AERUGINOSA IN CYSTIC FIBROSIS

The study will determine through a Phase III, placebo-controlled clinical trial whether the compound Tobramycin is safe and efficacious in the treatment of Pseudomonas aeriginosa in patients with cystic fibrosis.